Developmental Program

Developmental Program Project Summary: Per the RFA of this U54 grant, we have set aside $70,000/year for the development of Pilot Projects to extend the capabilities of the proposed Center and introduce new capabilities, as we progress in the five year performance period. We have also raised substantial funds from Stanford ($2,250,000) over 5 years that will be used to identify and maintain additional seed projects, education, clinical translation, and outreach activities of the Center. These internally sponsored seed projects and other activities will be at no cost to the NCI.